Implementation of DDInteract: A Shared-decision Making Tool for Anticoagulant Drug-Drug INTERACTions

Project Summary:
Both warfarin and direct-acting anti-coagulants (DOACs, i.e. apixaban, dabigatran, edoxaban, and
rivaroxaban) are widely used to prevent thrombosis due to atrial fibrillation and other clotting disorders.
Individuals receiving anticoagulants often have multiple comorbidities requiring other medications, and
exposure to multiple therapies increases the risk of bleeding due to drug-drug interactions (DDIs). Current
electronic health records (EHR) systems can provide warnings (i.e. alerts) about potential interactions, but
these warnings are text-based, are non-specific beyond stating the interaction is “major” or “contraindicated”;
and lack any medication or patient attributes that affect the likelihood of harm. Our team has developed and
tested a novel share decision making (SDM) tool called DDInteract, designed to reduce exposure to
anticoagulant DDIs. This tool is interoperable within existing EHR systems. Our project uses a practical,
implementation science-based approach to promote the sustainable uptake of DDInteract to reduce exposure
to clinically important anticoagulant DDIs. Through an implementation science framework, we will enable
prescribers and patients to better understand the risk/benefit calculus so they can work together to minimize
the risk of harm. Our approach is preferred over standalone web-based SDM tools because 1) DDInteract can
be seamlessly launched within the EHR without having to open and authenticate against a separate
application; 2) it automatically pulls relevant data (e.g., age, history of bleeding, other medications) from the
patient’s record to calculate a patient-specific risk; 3) it writes medication orders back to the EHR; and 4) it
automatically produces documentation for clinical notes and tailored patient instructions explaining the risk and
shared decisions made during the visit. In essence, this tool is a scalable out-of-the-box solution to the issue of
anticoagulant DDIs. The central hypothesis of this project seeks to evaluate whether DDInteract affects
exposure to potential DDIs and risk for bleeding among patients receiving an anticoagulant from before to after
implementation of DDInteract compared to providers from usual care sites. We will accomplish our objectives
and test our hypothesis by pursuing the following aims: Specific Aim 1: Examine contextual factors and define
relevant implementation strategies to facilitate integration of DDInteract within 3 University-based healthcare
systems; Specific Aim 2: Evaluate DDInteract in production/real-world situations to identify barriers and
facilitators to adoption and use of DDInteract and develop solutions to overcome those barriers; and Specific
Aim 3: Conduct a cluster randomized, multi-system trial to evaluate the effectiveness of DDInteract to mitigate
exposure to drug interactions involving oral anticoagulants. This project will greatly improve SDM for DDIs by
implementing this novel tool (DDInteract) in the participating clinics.

Public health relevance
Project Narrative Drug-drug interactions (DDIs) involving oral anticoagulants can lead to serious harm. To reduce harm from these dangerous combinations, creative solutions are needed that both increase the involvement of patients and harness the power of interoperable electronic health records. The purpose of this project is to disseminate a novel approach for DDIs that enhances shared decision making by providing a visual display of the potential for harm from anticoagulants and other medications, taking into account a patient’s unique attributes.